Targeting the stress-specific function of replication protein A in oral squamous cell carcinoma

Oral squamous cell carcinoma (OSCC) is a significant public health problem, with approximately
400,000 new cases and 200,000 deaths per year worldwide. First-line treatments for OSCC
typically include surgery and radiation, with chemotherapy added to enhance the efficacy of
radiation (chemoradiation), and to prevent cancer recurrence. Radiation and oral cancer
chemotherapeutics eliminate cancer cells largely by disrupting DNA replication to induce
replication stress and DNA damage, suggesting the therapeutic benefit of conjunctive targeting
of the DNA replication machinery. However, replication functions are essential for normal cell
proliferation, leading to unavoidable toxicity that limits the true clinical potential. In this project,
we explore a novel idea that the stress-specific function of an essential DNA replication factor
can be targeted to effectively and selectively confer toxicity in OSCC. The heterotrimeric
replication protein A (RPA) complex binds and stabilizes single strand DNA (ssDNA) via multiple
oligonucleotide binding (OB) motifs. RPA-ssDNA not only mediates DNA replication, but also
orchestrates replication fork stabilization, DNA repair and activation of the replication
checkpoint. Interestingly, a unique OB motif at the N-terminus of the RPA70 subunit (RPA70N)
mediates RPA’s binding to, not ssDNA, but multiple proteins involved in the replication stress
responses. We hypothesize that this RPA motif is targetable to enhance OSCC treatment
responses. RPA upregulation in OSCC has been associated with cancer resistance, and
replication stress is a well-established cancer hallmark, supporting the potential selectivity of the
treatment. We will develop new transgenic mouse models to study the impact of RPA
upregulation and RPA70N mutations on OSCC progression and treatment responses.
Combining with these mouse models, we will carry out proof-of-principle, pre-clinical evaluation
of a novel small molecule inhibitor of the RPA70N OB motif in OSCC treatment. Our multi-PI
team are poised to explore the proposed therapeutic idea, with complementary expertise in
RPA, transgenic mouse models, and OSCC.

Public health relevance
Oral cancer is a significant health problem in the US and around the world, the treatment outcome of oral cancer is poor and remains unimproved for decades. Here, we explore an interesting therapeutic idea to target the stress-specific function of replication protein A, to overcome oral cancer resistance and enhance therapeutic efficacy, using novel mouse models, a new small molecule inhibitor, and other innovative approaches.